Advance Clinical and Translational Research (Advance-CTR): Pragmatic Acceleration of Community-Engaged Education for Data-Driven Health Sciences (PACE-DHS)

ABSTRACT – OVERALL
The universities, hospitals, government agencies and community organizations in Rhode Island are well
positioned to bridge the gaps between the worlds of clinical and basic science. Rhode Island’s small size,
population demographics, and organizational structure are assets and present opportunities to implement and
test transformative clinical and translational research. The health care delivery environment within the state is
highly conducive to clinical research due to the relatively limited number of health care systems. Further
contributing to Rhode Island’s translational research infrastructure are a number of well-organized Institutional
Developmental Award (IDeA) Programs, each with core facility, faculty development and collaborative
research resources. But despite Rhode Island’s impressive educational institutions, streamlined clinical
environment, and successful IDeA sponsored research and mentoring programs, the majority of these
resources have not been coordinately focused towards developing a multi-institutional, clinical and
translational research infrastructure that would serve to improve the effectiveness of clinical practice and
health care policy in Rhode Island. The objective of the Advance Clinical and Translation Research Award
(Advance-CTR) is to bridge these infrastructure gaps by creating an overarching, multidisciplinary, central
organization to better coordinate and leverage existing resources for program management and thereby
provide the infrastructure necessary to address current and future health concerns in Rhode Island. The goals
of the Advance-CTR are to:
1. Educate, mentor and encourage young investigators in clinical research professional development.
2. Eliminate the obstacles that may prevent researchers from pursuing clinical research initiatives that can
lead to funded research programs.
3. Bring together the diverse clinical research resources to provide a virtual home that facilitates new
collaborations and enhanced efficiencies.
4. Facilitate research to gather preliminary data necessary for developing competitive research proposals.
5. Provide contemporary infrastructure for clinical and translational research including research planning
and implementation, advanced biostatistics and epidemiology support and biomedical informatics.
6. Foster coordination between translational researchers at our participating entities so as to create new
productive collaborations with translational outcomes.
7. Sustain a clinical translational research environment by providing the necessary management and
coordination of resources.
8. Create an innovative Tracking and Evaluation program that will combine support requests with use and
cost data and apply lessons learned in the CTSA program to the CTR environment.

Public health relevance
PROJECT NARRATIVE – OVERALL The Universities, Hospitals and Community Organizations in Rhode Island are well positioned to bridge the gaps between the worlds of clinical and basic science. Using the targeted resources of an IDeA-CTR Award, the Brown Institute for Translational Sciences, and a statewide consortium of collaborators, hospitals, universities, non-profit organizations and government agencies, will draw on the resources already developed in the NIH Institutional Development Award (IDeA) programs (core labs and faculty development programs) to enhance the Advance Clinical and Translational Research Program’s (Advance-CTR) ability to support clinical and translational research. We will serve as a bench-to-bedside research network and career development umbrella for the investigator community in affiliated institutions. In so doing, we will enhance patient-centered research and accelerate discoveries and health innovations to benefit our communities and to serve our State.